Effects of Intracortical Microstimulation on Neural Activity in Distant Cortical Regions

Electrical stimulation has been shown to be a useful technique for delivering information to the brain
from brain-machine interfacing technology. The brain is remarkably capable of learning to interpret such
information, most notably demonstrated by the success of cochlear implants. Learning to translate stimulation
into useful information can be attributed to neural plasticity, yet little is known about the relationship between
localized electrical stimulation and subsequent effects on brain regions distant from the simulation site. In the
specific context of stimulating cortical gray matter, or intracortical microstimulation (ICMS), a common
assumption is that post-stimulation effects remain localized to a small volume of neurons near the stimulating
electrode. However, there is evidence that suggests the effects can spread substantial distances.
Prior work in my lab has shown that subjects can learn to interpret ICMS delivered to four different
electrodes in the primary somatosensory cortex (S1) as instructions to perform four different arbitrarily-
assigned movements. My preliminary studies using that dataset suggest that ICMS delivered in S1 can have
two types of effects on neurons in distant cortical areas: 1) ICMS pulses can directly elicit spikes in neurons
from both ventral premotor cortex (PMv) and primary motor cortex (M1) – either antidromically,
monosynaptically, or oligosynaptically – which I term “direct driving”. 2) Other neurons not directly driven by the
ICMS pulses may nevertheless fire differently between trials instructing the same movements with only trains
of ICMS pulses versus with only visual cues, which I term “instruction-modality dependent modulation”. Thus,
the effects of ICMS may extend to parts of the cortical network more distant than previously appreciated.
I propose to investigate the effects of ICMS instructions for arbitrarily-associated movements delivered
in S1 on several distant cortical areas involved in motor control. Specifically, I will study effects in seven frontal
and parietal regions: pre-supplementary motor area, dorsal premotor cortex, ventral premotor cortex, rostral
primary motor cortex, caudal primary motor cortex, anterior intraparietal area, and dorsal posterior parietal
cortex. Aim I will examine which of those cortical areas contain neurons that are directly driven by ICMS pulses
delivered in S1. Aim II will examine which of those cortical areas contain neurons that show instruction-
modality dependent modulation. The proposed studies will show the extent to which ICMS in S1 modulates
distant parts of the cortical network, and how such modulation develops over time as subjects learn to use the
ICMS as instructions to perform arbitrarily-associated movements. That information can be used to design
inputs to cortex from brain-machine interfacing technology that is clearer to the subject and encourages
healthy plasticity to reduce cognitive demand during the training process. Those improvements serve to benefit
patients with diseases of the nervous system that can be treated with brain-machine interfacing technology
including stroke, sensory neuropathies, or head trauma.

Public health relevance
PROJECT NARRATIVE Electrical microstimulation may prove to be a useful technique for delivering information from neuroprosthetic devices to the cerebral cortex. Current efforts to understand how the brain uses such information have focused on the effects of stimulation on nerve cells in close proximity to the electrode tip, though electrical stimulation may influence neural activity far from the stimulation site. The proposed studies will test the hypothesis that electrical stimulation affects nerve cells in distant cortical areas as the brain learns to interpret the stimulation and quantify how those effects evolve over time with training, which will provide insights for improving the utility of electrical stimulation in neuroprosthetic devices.